Institutional Career Development

Contact PD/PI: Murphy, Timothy F Inst-Career-Dev-001 (493)
KL2 Mentored Career Development Award. The CTSA-Linked KL2 mentored career development award
program (KL2 program) will strive to engage talented and motivated scholars to join the clinical and translational
science workforce with the goal of developing new diagnostic, preventive, and therapeutic interventions for
diseases, with an emphasis on addressing health disparities. The KL2 program has stimulated clinical and
translational research across the Buffalo Translational Consortium (BTC) by attracting, mentoring, training and
engaging scholars with diverse cultural, ethnic, racial and professional backgrounds and across scientific
disciplines (i.e. RN-PhDs, PharmDs, PhDs, MDs, and/or DDS-PhDs). These scholars receive an
interprofessional and interdisciplinary education where they learn with, about, and from each other, enabling
effective collaboration and discoveries in clinical and translational research. In the proposed funding period, the
KL2 program will train at least four junior faculty physician scientist scholars by supporting them for two years
on their path to independence, with the option of receiving an additional third year of institutional funding upon
completion of the program curriculum and objective evaluation of scholarly accomplishments. The program is
complemented by and integrated with the institutionally-funded BTC scholars program, allowing us to train five
(three in years 1-3; two in years 3-5) additional scholars under the same terms during the next funding period.
Integration of all scholars’ activities under our well-established mentoring and training program brings together
a critical mass of diverse professional experiences and talent benefiting all involved. The KL2 program has three
specific aims towards these goals are: 1) attract skilled and motivated early career clinical and translational
investigators from a broad range of health science disciplines, including individuals underrepresented in health
science; 2) provide comprehensive tailored support to mentor and train the scholars to promote pathways to
independence; and 3) engage scholars, facilitate interactions and enhance communications with the community
to raise awareness and accelerate solutions for health disparities. Innovations in our KL2 program include the
awarding of digital badges followed by micro-credentials, which are competency-based documentation of training
in specific areas; inclusion of community agency advisors and partners on scholars’ mentoring teams, aligning
with our goal to address health disparities in our community; and extensive partnering with other CTSA hubs.
The program will mentor, train and develop KL2 scholars’ professional skills and facilitate a seamless transition
to their next career level in the clinical and translational workforce. The overall goal of this KL2 program is to
develop the next generation of 21st century leaders whose backgrounds mirror the diversity of our community to
enhance excellence in clinical and translational research, locally and across the nation.